PHASE I TRIAL OF CYCLOSPORINE AND DOXORUBICIN IN CHEMOTHERAPY

This protocol will study the effects of cyclosporine on doxorubicin pharmacokinetics, and also will determine the maximum tolerated dose of doxorubicin which can be administered in conjunction with cyclosporine.